IND-enabling studies of D6PV- a novel ApoC-II peptide mimetic therapeutic

PROJECT SUMMARY
The goal of the current study is to complete IND enabling studies to develop a therapeutic based on
D6PV, a novel ApoC-II peptide mimetic, by conducting toxicology studies and manufacturing GMP drug
substance and engineering validation of drug product for future Phase 1 trials in normal healthy
volunteers. Successful completion of aims proposed here will result in the development of a novel
peptide mimetic as an intravenous formulation with a rapid onset of action for the treatment of
hospitalized patients with acute pancreatitis to rapidly reduce triglycerides to prevent or treat
hypertriglyceridemia, and therefore will reduce the length of stay in the hospital and reduce or eliminate
the morbidity and mortality. A safety assessment will be completed in IND enabling studies and a
NOAEL (no adverse effect load) determined to support first-in-human dosing. This will enable Protean
Bio to advance D6PV for Phase 1 clinical trials in normal healthy volunteers to evaluate the
pharmacokinetics, safety and tolerability of D6PV after single and multiple ascending dosing regimens.
Once completed and demonstrated to be safe in humans, D6PV is anticipated to progress to Phase 2
trials in hospitalized AP patients for proof-of- concept (i.e., efficacy) for reducing triglycerides in < 4
hours after administration as an intravenous dose. AP is one of the most common diagnosis for GI-
related hospitalization with significant morbidity and at an annual cost of $2.6B. Severe
Hypertriglyceridemia (SHTG) is a leading cause for AP and is known to occur in up to 38% of patients
with plasma triglyceride (TG) levels of 3000-5000 mg/dL. Although there are several approved products
(e.g., Vascepa®, Epanova®) and new modalities (nucleic acid drugs, antibodies) in Phase 2/3 trials for
the treatment of SHTG, they have a delayed onset of action, rendering them unsuitable for rapidly
lowering triglycerides in hospitalized AP patients. Therefore, there is a clear unmet need for rapidly
addressing elevated TG in AP patients in an acute, hospitalized setting to reduce pain and progression
of pancreatic necrosis, organ failure and mortality. Superior ex vivo results were confirmed in in vivo
studies in mice models of HTG, demonstrating a ~80% reduction of plasma HTG in 3 hours post dosing
and ~85% decrease in plasma ApoC-III; the latter due to displacement by D6PV and subsequent
clearance. In this Phase IIB grant proposal, we propose to complete Pre-IND meeting with the FDA,
IND enabling GLP toxicology studies and manufacturing of GMP drug substance and engineering
validation of drug product.

Public health relevance
NARRATIVE Protean Bio has identified a novel peptide mimetic (D6PV) and the goal of the current proposal is to complete Pre-IND meeting with the FDA. Feedback from this meeting will provide guidance for completion of IND enabling GLP toxicology studies, manufacturing of GMP drug substance and engineering validation of GMP drug product. Successful completion of these studies will enable progression of D6PV towards clinical trials.